Thermostable Inactivated Potent Yellow Fever Vaccine

Summary
Yellow Fever (YF) is an acute viral hemorrhagic fever disease caused by Yellow Fever
virus (YFV) and an estimated 200,000 YF infections occur annually. Approximately 50% of
infected individuals that develop a severe case of the disease will die. The infection is
common in Africa and South America, and travelers and residents of those areas are at
high risk of contracting the virus. A recent resurgence of YF in Africa and South America
has exposed the YFV vaccine supply shortage that is insufficient to fight this major public
health problem.
In this project, Universal Stabilization Technologies (UST) in collaboration with University of
Texas Medical Branch (UTMB) will apply UST’s novel approach for development of
thermostable, inactivated, and potent vaccine against YF starting with wild-type YFV. The
YFV will be stabilized at ambient temperatures (AT) using UST’s patented “Preservation by
Vaporization” (PBV) technology and subsequently inactivated at AT using electron beam
(EB) irradiation procedure to produce inactivated and potent vaccine against Yellow Fever.
The EB inactivation has been found to inactivate through virus nucleic acid damage without
affecting virus surface structures, thus preserving integrity of epitopes, or antigenic
determinants recognized by the immune system, while preventing virus replication.
The specific aims for this project are the following:
• Aim 1: Produce thermostable, electron beam (EB) inactivated Yellow Fever
vaccine candidate.
• Aim.2. Perform long-term stability testing at low, medium, and high ambient
temperatures: 4⁰C. 25⁰C. 37⁰C and short-term testing at 70⁰C.
• Aim 3. Evaluate protective efficacy of the YFV vaccine candidate against
viscerotropic YF in a hamster model.
Our immediate goal is to prove feasibility of a safe, effective, low-cost thermostable
vaccine against Yellow Fever virus. The technologies developed in this project could
eventually provide a platform technology for quick development of safe, thermostable,
and effective vaccines against other emerging diseases.

Public health relevance
Project Narrative This research first explores feasibility of producing a safe, effective, low cost thermostable vaccine against Yellow Fever virus, which could ultimately be administered to patients via respiratory or non-needle delivery. For this project, wild-type Yellow Fever virus will be thermostabilized by Universal Stabilization Technologies’ innovative “Preservation by Vaporization” process, followed by electron beam inactivation to create a potent vaccine. The technologies developed in this project could eventually become a platform technology for quick development of safe, effective, and thermostable vaccines against other infectious diseases.